Fine-scale Spatiotemporal Mapping of Cellular Regulatory Networks Directing Heart Development

Project Summary
Congenital Heart Disease is the most common congenital anomaly in newborn babies, accounting for one third
of all major congenital anomalies. Despite recent congenital heart disease genetic studies highlighting the
critical role of cardiac transcriptional and chromatin regulators during heart development, our understanding of
how these developmental regulators interact to create the dynamic gene regulatory networks that mediate
heart development remains to be fully elucidated. Thus, we propose to define and assay the cardiovascular
developmental regulators and their gene regulatory networks that direct the development of the vast array of
cardiovascular cell types creating the mammalian heart. To achieve this goal, a multi-disciplinary experimental
and computational systems biology approach will be implemented to: (1) elucidate gene regulatory networks
that establish the cardiogenic cellular hierarchy of the developing mammalian heart, (2) investigate the
spatiotemporal organization of the cardiogenic cellular hierarchy during mouse embryogenesis and heart
morphogenesis and (3) functionally examine how distinct cardiovascular developmental sources create specific
cardiovascular lineages contributing to the developing heart.

Public health relevance
Project Narrative This proposal seeks to illuminate the cardiogenic cellular hierarchy and the gene regulatory networks that determine the origins and fates of distinct cardiovascular progenitor cells during heart development. Results from these studies will yield new insights into how disrupted cardiovascular regulatory networks lead to congenital heart disease and how they may be modified to develop treatments to improve patient outcome.